Targeting the evolving immunopeptidome of metastatic colorectal cancer

Targeting the evolving immunopeptidome of metastatic colorectal cancer
There has been limited success of chimeric antigen receptor (CAR) T cell therapies in solid tumors, in
part, due to the inability to identify cancer-specific targets. Exploring the immunopeptidome, peptides
presented by human leukocyte antigen (HLA) class I molecules, can expand the repertoire of targetable
antigens. Our recent findings show that metastatic colorectal cancer (mCRC) cells adopt a highly
stereotyped fetal-like phenotype, characterized by activating a developmental WNT-signaling signature
as a mechanism of cell-fate reprogramming. This transcriptional signature is accentuated in metastasis
initiating cells relative to the primary tumor and is highly conserved across diverse patients. Therefore,
we hypothesize that these changes will translate into a cancer specific immunopeptidome and reveal a
conserved and targetable sequence. Using our established integrated platform for the collection and
multimodal analysis of resected normal colon, primary and metastatic lesions from patients undergoing
CRC surgery, we have harnessed ex vivo patient-derived organoids (PDOs) that recapitulate patient-
specific CRC cell states. Preliminary analysis using PDOs from HLA-A*02:01+ patients, the most
common HLA allele, identified peptide targets derived from these fetal WNT-pathway gene states,
specifically NKD1, that are both specific and prevalent in CRC and are lacking in healthy tissues.
Furthermore, we showed that these peptides retain their immunogenicity based on healthy donor T cell
reactivity. In Aim 1 (K99), we will systematically elucidate the evolving immunopeptidome from normal
colon, primary tumor and metastatic lesion PDOs through mass-spectrometry and identify conserved
intracellular targets for therapeutic interventions. In Aim 2 (K99), we will validate the biological role of
NKD1 in CRC development, invasion, and metastasis by modulating its expression in metastatic lesion
PDOs in an orthotopic xenograft mouse model. In Aim 3 (R00), we will identify NKD1-reactive T cell
receptor (TCR) clones from HLA-A*02:01+ CRC patient’s peripheral blood to develop engineered TCR-
T cell therapies. Drawing on my expertise in human immunology and medical oncology, along with the
mentorship of prominent CRC biologist Dr. Karuna Ganesh and immunopeptidome-based therapy
expert Dr. David Scheinberg at the outstanding Memorial Sloan Kettering Cancer Center, I am well-
equipped to address these research questions. This foundation will enable me to master the necessary
techniques, acquire knowledge, and develop the leadership skills required to emerge as a leading
independent researcher and physician-scientist in the field of immuno-oncology.

Public health relevance
Metastatic colorectal cancer (mCRC) cells exhibit an essential and unique fetal WNT-signaling signature for dissemination and renewal, consistently observed across multiple patients despite varying genomic mutations. Immunopeptidomic analysis of patient-derived organoids (PDOs), which provide a an effectively inexhaustive reservoir of clinically relevant cancer cells, reveals the presentation of peptides associated with fetal WNT signaling on the cell surface, offering insights into novel cancer targets. Through detailed and comprehensive studies of PDOs, we aim to uncover the evolving immunopeptidomes in advanced disease and the role of NDK1 in the establishment of metastases, paving the way for identifying T cell receptors for novel cellular therapeutic strategies.